Novel small molecule biosynthetic gene clusters in Streptococcus mutans and virulence of dental caries

Project Summary
Dental caries is a global infectious disease impacting the lives of 80% of the human population.
Severe early childhood caries (SECC) is of particular concern and characterized by extensive tooth
decay that can dramatically affect the dental health of children under six years of age. This
constitutes a significant economic burden, can have dramatic impact on the child’s well being and
may contribute to overall health later in life. Streptococcus mutans is the bacterium most commonly
associated with initiation of SECC and early childhood caries (ECC). Biosynthetic gene clusters
(BGCs) in bacteria often encode genes for small molecules and other antimicrobial peptides. This
research plan proposes to investigate a novel BGC (butyrolactone-ladderane hybrid, BL-BGC) of
S. mutans from a high caries risk population to identify its impact on S. mutans virulence and survival
traits. Preliminary data suggests the BL-BGC is significantly up regulated in dental caries and occurs
in the most prevalent strain type of S. mutans within a high-caries risk study population. The
hypothesis is that clinical S. mutans strains with the BL-BGC will have increased virulence properties
and cariogenicity. Aim 1 will characterize phenotypes of clinical S. mutans strains containing the BL-
BGC and their association with dental caries key virulence and survival traits using gene mutagenesis
and in-vivo biofilm analysis. Aim 2 will determine the impact of BL-BGC on expression of virulence
genes and metabolites in S. mutans biofilms using RNA-sequencing and metabolomics analysis. Aim
3 will determine the how BL-BGC impacts S. mutans colonization and virulence using animal models
of dental caries. The proposed study will elucidate the role of BL-BGC in S. mutans virulence and
fitness during the K99 phase. Metabolites produced by S. mutans with BL-BGC impacting key
virulence traits will be purified and characterized in the R00 phase, providing new insights into
S. mutans’ role in the pathogenesis of dental caries. Characterization of this and other BGCs may
lead to new therapeutic targets designed to reduce, reverse, or even prevent SECC. The K99 phase
of this award will provide the time and support for additional research training, building effective
collaborations, enhancing professional development and submission of publications leading to a
successful transition to an independent academic research appointment in the R00 phase. This study
is unique in the use of BGCs from clinical S. mutans isolates from a high-risk caries population
allowing for clinical translation of results and the use of metabolomics for identification of BL-BGC
related compounds/metabolites. This study will enable an independent career path by establishing a
multidisciplinary program utilizing molecular biology approaches to validate epidemiological
associations, bridging these fields and advancing the knowledge of S. mutans virulence in caries.

Public health relevance
Project Narrative Severe early childhood dental caries (SECC) constitutes a significant economic burden, can have dramatic impact on a child's well being and may contribute to overall health later in life. Studies of clinical Streptococcus mutans strains are needed to investigate the diversity of novel small molecule metabolites produced by biosynthetic gene clusters and their impact on the pathogenesis of dental caries. Identification of novel metabolites from cariogenic S. mutans may lead to the development of new therapeutics that can effectively treat or even prevent SECC.